MOTOR NEURON DISEASE

The goal of this Motor Neuron Disease (MND) Program Project Grant is to delineate principles underlying the selective vulnerability of the motor neuron. We plan to elucidate motor neuron-specific properties as well as factors that selectively act on motor neurons. The individual projects are: Project 1 (Siddique) - Gene mapping studies in MN disorders; Project 2 (Roos) - Theiler's virus genes and gene products which determine neurotropism and neurovirulence; Project 3 (Miller) - Excitatory amino acid receptors in motor neuron physiology; Core A - Clinical-scientific core that acts as a source of clinical information and specimens for members of the Program Project and involves experimental treatments, studies of familial MND, and neurophysiological, morphological and immunological studies of post-poliomyelitis syndrome; Core B - Administrative core. Our hope is that knowledge gained from the varied Projects in this grant may increase our understanding of human MND and lead to rational and effective treatments.